Boston University Clinical and Translational Science Institute

SUMMARY
1. Summary of the funded parent grant (BU CTSI)
The overall theme of the Boston University Clinical and Translational Science Institute (BU CTSI) is to
explore and solve major challenges in translational science, especially those that address the special
health problems of disadvantage individuals from urban at risk communities by developing and
deploying new tools, methods and processes to expedite clinical research in our hub and nationalize
shared unique resources with the CTSA Network. To do this we will exploit our strengths in developing
multi-disciplinary, multi-cultural collaborative teams across diverse programs. This approach follows on the BU
CTSI’s history of actively engaging in continuous and vigorous dialogue within its own hub, with other CTSA
hubs, and with NCATS to identify opportunities to catalyze clinical and translational research locally and
nationally. Our goals are:
Goal 1. Discover, demonstrate, deploy and disseminate novel programs to develop our entire translational
science workforce.
Goal 2. Further enhance our robust translational science environment to encourage all aspects of translational
research, from scientific discovery to an efficient clinical research enterprise, exploiting our strengths in basic
and clinical science, and in so doing address the health disparities of our at risk diverse patients and make the
lessons learned and resources developed from our partners and affiliates available to the CTSA network.
Goal 3. Effect meaningful multi-directional relationships among all our community stakeholders (patients,
providers, purchasers, payers, public policy makers/advocates, product makers and principal investigators) to
strengthen collaborative translational research across the lifespan of our special populations and enable novel
approaches to integrating research into health care in our ACO.
Goal 4. In collaboration with other CTSA Hubs, discover, develop and disseminate innovative tools, methods
and programs to improve research on treatments and diagnostics that address our local and national health
problems.
Goal 5. Develop and demonstrate novel informatics innovations to Improve local Hub translational research in
our unique learning health system and disseminate these innovations to the CTSA Network.
The BU CTSI’s vision is to be the strongest possible advocate for, and participant in, translational research that
serves the health needs of our diverse at risk URG patient populations by empowering our community and
creating unique resources that can be integrated with and distributed to the national CTSA network.

Public health relevance
Relevance/Narrative. The BU CTSI is located in the South End of Boston, amidst the greatest concentration of ethnically and racially diverse people of low socioeconomic status in New England. The mandate to care for these individuals drives the theme of our CTSA: to create novel approaches to improving the health of disadvantaged at risk individuals through the lessons learned from translational research.